Georgetown University Initiative for Maximizing Student Development (IMSD)

Project Summary
The Georgetown University Initiative for Maximizing Student Development (IMSD) will bring together 61 faculty
from 7 graduate programs and departments across Georgetown to develop a cadre of diverse and
interdisciplinary scholars for careers in the biomedical scientific workforce. The overarching program goals are
to expand diversity of our PhD student population, build a community of interdisciplinary scholars, facilitate career
self-efficacy, and establish a community of practice in inclusive mentorship. Each year, six IMSD Trainees will
enter the program and be supported for years 1 and 2. Year 1 will consist of foundational coursework in their
respective disciplines with access to interdepartmental electives, cohort development activities, and research
rotations. All IMSD Trainees will complete a core Survival Skills course that focuses on scientific rigor, science
communications, proposal development, and responsible conduct of research. Scholars will also complete a
course in Celebrating Difference that helps them navigate institutional cultures, develop leadership skills, and
synergize their sociocultural and science identities. During year two, trainees will join thesis research laboratories
and form cross-disciplinary mentorship teams tailored to their individualized interests and career development
needs. The mentoring team structure will broaden the trainee’s scientific skills and career perspectives, as well
as foster cross-departmental scholarship. Additionally, IMSD Scholars will develop cross-sector professional
management and communications skills by completing project management and communications curriculum.
Scholars will also complete experiential immersion projects with administrative partners on campus or with offsite
partners in industry or policy sectors. Participating faculty will complete training in effective and inclusive
mentoring practices using the Entering Mentoring Train the Trainer curriculum that we’ve previously replicated
at Georgetown University. To integrate our faculty into the IMSD recruitment process, we will partner with the
University of the District of Columbia (UDC), a Historically Black College and University, to provide paid summer
mentored-research experiences to undergraduates to develop our applicant pipeline. This pipeline development
initiative will build a strong mentorship network for prospective students, IMSD Scholars, IMSD Affiliates
(advanced graduate students who have completed their 2 years of direct support), and faculty, establishing a
‘vertical’ community of scholars at different stages of their professional development. Furthermore, we will build
community and peer accountability among our IMSD Trainees, and in parallel among their faculty mentors, by
utilizing a Power of Peers (POP) circle peer-coaching model framework. IMSD POP circles provide participants
with a self-sustaining structure to problem solve and address career development issues with a community of
peers. Faculty mentor POP Circles will share equitable mentoring practices and build a robust community of
practice in equitable training that spans department boundaries.

Public health relevance
Project Narrative The Georgetown University Initiative for Maximizing Student Development (IMSD) will expand the diversity of our PhD student population, build a community of interdisciplinary scholars, facilitate career self-efficacy, and establish a community of practice in inclusive mentorship. We will welcome a yearly cohort of PhD students from underrepresented backgrounds, from across 7 PhD programs on the Georgetown Main and Medical Center campuses, train them in foundational research skills and experimental design, and set them up with faculty mentoring teams. We will provide our students with cross-departmental and cross-sector skills training and professional experiential learning opportunities, and facilitate their growth as near peer mentors. Trainees will transition into their thesis research projects empowered with a sustained network of professional resources and interdisciplinary scientific skills to prepare them for broad careers in the scientific workforce.